Automating Behavioral Coding via Text-Mining and Speech Signal Processing

DESCRIPTION (provided by applicant): Numerous clinical trials have shown that Motivational Interviewing (MI; Miller & Rollnick, 2002) is an efficacious treatment for alcohol use disorders (AUD) and related health behavior problems (e.g., Burke, Dunn, Atkins, & Phelps, 2005), but much less is known about the therapy mechanisms of MI (Huebner & Tonigan, 2007). Process research has typically relied on behavioral coding schemes such as the Motivational Interviewing Skills Code (MISC; Miller, Moyers, Ernst, & Amrhein, 2008). Although MI mechanism research with the MISC has produced some of the best data to date (e.g., Moyers et al., 2007), behavioral coding has a number of limitations: 1) it is phenomenally labor intensive, 2) objectivity, reliability, and transportability of coding can be challenging, and 3) it is inflexible (i.e., any new codes require completely new coding). The current proposal brings together a highly interdisciplinary team to develop linguistic processing tools to automate the coding of the MISC and Motivational Interviewing Treatment Integrity (MITI; Moyers, Martin, Manuel, Miller, & Ernst, 2007). The coding of both systems is based on two types of linguistic data: what is said, and how it is said. Our team members in computer science, cognitive science, and electrical engineering are leading researchers in text-mining and speech signal processing, and their methods will be applied to MI transcripts and recordings to automate coding of the MISC/MITI. The core, methodological tool will be topic models (Steyvers & Griffiths, 2007), Bayesian models of semantic knowledge representation. Topic models identify groupings of words that constitute meaning units (or topics), and a recent extension models coded data (e.g., MISC) in which the model learns what specific text is associated with specific tags. Two specific aims encompass the current proposal: 1) Assess the accuracy of topic models to automatically code the MISC/MITI using transcripts and audiofiles of MI sessions, and 2) Test MI theory (within session and long-term outcome) using approximately 1,167 sessions of MI coded in Aim 1. These aims will be accomplished using three MI intervention studies: two studies focused on college student drinking and one hospital-based study of drug abuse. The long-term objectives are to use innovative linguistic tools to study therapy mechanisms and develop more efficient systems for collecting psychotherapy process data. Alcohol use disorders continue to represent an incredible societal burden in terms of death, health complications, fractured relationships, and economic costs. The current research will provide innovative tools for studying why therapy works, which in turn can help to ameliorate some of the deleterious effects of AUD.

Public health relevance
PUBLIC HEALTH RELEVANCE: Research focused on psychotherapy mechanisms of alcohol use disorders (AUD) have often relied upon behavioral observation coding schemes, such as the Motivational Interview Skills Code (MISC), which are time consuming and can present difficulties with reliability. The current, interdisciplinary proposal develops methods for automating behavioral coding through applying recent advances in text-mining and speech signal processing. Project Narrative Research focused on psychotherapy mechanisms of alcohol use disorders (AUD) have often relied upon behavioral observation coding schemes, such as the Motivational Interview Skills Code (MISC), which are time consuming and can present difficulties with reliability. The current, interdisciplinary proposal develops methods for automating behavioral coding through applying recent advances in text-mining and speech signal processing. __SpecificAimsTextDelimiter__ A. Specific Aims Psychotherapy intervention studies collect audio and/or videotapes of therapy sessions to use in treatment adherence and process research. These tapes record the complex series of interactions between therapist and client, and as such, they encode the active ingredients of the therapy - when the therapy works, the tapes should tell us why. Heretofore, the best method for psychotherapy process research has been observational coding - developing and applying a theory-driven coding system to identify relevant behaviors, language, and emotions in clients and therapists. Within research for alcohol use disorders (AUDs) based on motivational interviewing (MI; Miller & Rollnick, 2002), the Motivational Interviewing Skills Code (MISC; Miller, 2001; Miller, Moyers, Ernst, & Amrhein, 2008) has yielded some of the best data thus far on how MI works (e.g., Moyers et al., 2007). Yet coding has critical shortcomings: 1) it is phenomenally labor intensive, 2) reliability can be challenging, 3) coder drift and retraining can be problematic, 4) it is inflexible (i.e., any new codes require completely new coding), and 5) it does not "scale up" for larger coding projects (i.e., there is not economy of scale). Thus, these methods of coding limit our ability to better analyze and understand the active ingredients of psychotherapy. We propose to address these limitations of observational coding methods and robustly test MI theory by automating behavioral coding of the MISC and its derivative, the Motivational Interviewing Treatment Integrity (MITI; Moyers, Martin, Manuel, Miller, & Ernst, 2007) coding system, using innovative methods for linguistic processing from cognitive science, computer science, and engineering. Topic models for semantic meaning and speech signal processing for encoded arousal will allow our models to include the meaning of what is said as well as the more subtle, but equally important, emotional tone with which it is expressed. Topic models (Steyvers & Griffiths, 2006) are Bayesian probabilistic models that can automatically extract semantic themes from text. Topic models take text documents as input (e.g., emails, abstracts, essays, news articles) and decode them into substantive, semantic units underlying the words - the topics or meaning. In a recent extension of the topics model (called concept-topic models), the model has been applied to coded documents (e.g., Wikipedia entries). In this extension the model learns the associations between the text of the document and external tags or categories. The current proposal will use this extension to map the text in MI transcripts to the MISC behavioral codes of those transcripts. Speech signal processing extracts acoustic features (e.g., pitch, speech rate, intensity, spectral energies) from audiofiles of spoken language which in turn can be used to provide information on what was spoken (i.e., the words) and how it was spoken (i.e., emotions). Acoustic features are associated with emotional arousal (Juslin & Scherer, 2005) and can be used to identify basic emotions (Lee & Narayanan, 2005; Grimm, Kroschel, Mower, & Narayanan, 2007). This offers an easily available method of assessing physiological arousal and emotional tone in conversation, requiring only a reasonable audio recording. Additionally, speech signal processing capabilities include automatically mapping acoustic features to text, that is automatic speech recognition. The current proposal will use speech signal processing methods to: automate transcription of texts, parse transcripts by speaker, time-stamp transcripts, and extract acoustic features as inputs to topic models. The proposed research will 1) use topic models combined with acoustic features from speech signal processing to learn associations between text, acoustic features, and the categories of the MISC/MITI and assess their accuracy in automatically coding new transcripts, and 2) use output from topic models and acoustic features to test MI theory that specific within-session linguistic relationships predict therapeutic behavior change post-therapy. Using MISC/MITI-coded transcripts from three MI intervention studies, we will train topic models to automatically identify the categories of the MISC/MITI and assess its accuracy in automatically coding new transcripts. Two extensions are planned to topic models: 1) map acoustic features of spoken language to text and include the tone of what is said in topic models, and 2) model the linguistic dependence between therapist and client across time within a session (via a Markov model). Aim 1 includes four components: a. Test the accuracy of concept-topic models to automatically code MISC/MITI in transcripts of MI interventions, compared to another established linguistic model, Latent Semantic Analysis (LSA). b. Include acoustic features as additional inputs to the topic model and compare accuracy to the models in 1a. c. Include a dynamic model of conversational language to model 1b and test accuracy of coding MISC/MITI relative to 1b. d. A final sub-aim is to examine whether the models listed in 1a-1c can be used on transcripts coded with the MITI (a simpler system, derived from the MISC) to generate MISC codes, an option that could increase cost effectiveness and ease of coding. Aim 1 will result in slightly more than 1,150 sessions of MITI/MISC coded transcripts from three MI intervention studies. Aim 2 includes two components focused on using the output of the linguistic tools to test MI theory of within session behavior and long-term behavioral outcomes: a. Using over 1,150 sessions worth of MISC/MITI data coded via our linguistic tools in Aim 1, we will replicate the associations of MI adherence with in-session client commitment language and change-talk, which in turn predict long-term outcome. b. Exploratory analyses will use the topics model output (as opposed to MISC/MITI codes) to assess new predictors of long-term outcome. All of the tasks in the current proposal will be undertaken by a strong, interdisciplinary research team, including experts from computer science, cognitive science, and engineering with expertise in text-mining and speech signal processing. These technical, basic science researchers will work collaboratively with leading intervention researchers in MI. The proposed research wills use "basic" science methods to not just improve coding of therapeutic process but to potentially reveal previously unidentified mechanisms of therapeutic change. If this is beneficial, the same approach might be used on other therapies and might be extended to other areas of study such as the analysis of qualitative data. Thus, the current proposal has implications well beyond the particular aims specified above, including a completely new approach to therapy process research and the analysis of clinical text (e.g., written notes in charts, open-ended text, recorded doctor-patient conversations, etc.).